Neutralization of primary HIV-1 viruses

Project Summary/Abstract
Many potent and effective broadly neutralizing antibodies (bNAbs) directed to the HIV-1 envelope glycoprotein
(Env) trimer have been studied mechanistically and structurally. Combined, their epitopes now cover most of the
external surface of Env. Passive immunization with bNAbs, optimally mixed to minimize viral escape, holds
promise for controlling HIV-1 infection, prevent it, or even helping to cure it. Eliciting bNAbs by active
immunization, however, remains problematic. Our overall long-term goal is to contribute to solving that major
problem. We will develop techniques for quantifying concentrations, affinities, kinetics, and stoichiometry of bNAb
binding in polyclonal sera from infected or immunized animals and humans. We will determine how these
quantities change as germline (GL) responses mature into bNAbs. So far, we have used soluble, native-like
SOSIP trimers to dissect or induce Ab responses. The recent emergence of mRNA vaccination, however, allows
the design of full-length Env constructs, opening the possibility of presenting external bNAb epitopes located
near the membrane while shielding C-terminal neo-epitopes at the base of soluble trimers. We will therefore
make virus-like particles that mimic HIV-1 virions in size, membrane composition, Env density, and Env
interactions with interior viral proteins. The kinetics and stoichiometry of bNAb binding to these full-length
membrane-anchored trimers, with and without changes in the cytoplasmic tail, will be compared with binding to
SOSIP trimers. We will also extend in-depth binding analyses to SOSIP trimers derived from a global panel of
neutralization-resistant HIV-1 isolates. We will dissect binding kinetics, stoichiometry, induced conformational
changes, and the heterogeneity of the interactions, thereby identifying binding characteristics that correlate with
neutralization breadth. In silico analyses of how the midpoints and Hill slopes (h) of the neutralization curves
relate to neutralization breadth, for both single bNAbs and combinations, will guide further experimental
dissections of how binding properties mold cross-reactivity. We will develop assays for measuring entry-fusion
fitness to define the relationship between viral resistance to bNAbs and the efficiency of receptor-facilitated entry.
To achieve these goals, we propose three Specific Aims:
Aim 1. Analyze bNAb binding and neutralization properties relevant to passive and active immunization.
Aim 2. Determine how bNAb breadth and binding properties are interrelated.
Aim 3. Dissect the relationship between entry fitness and escape from bNAbs.
In summary, we seek to define how dynamic properties of Ab binding are linked to neutralization breadth. Such
fundamental information may help improve both active and passive immunization strategies, which are highly
relevant to public health.

Public health relevance
Project Narrative The proposed research seeks knowledge that will inform effective strategies for a vaccine that protects against HIV-1 by inducing broadly active neutralizing antibodies, and for using such antibodies optimally to treat infection. The research is therefore relevant to public health because, according to UNAIDS, as of 2021 38 million people were living with HIV, of whom 10 million lacked access to antiretroviral therapy, while 1.5 million people became newly infected with the virus and 650,000 died from AIDS and related illnesses that year. The application focuses on the molecular basis of the binding by neutralizing antibodies in relation to their breadth and efficacy of action, aiming to inform not only vaccine development but also the use of neutralizing antibodies to treat or prevent infection.